Mates in Motion: Feasibility and Acceptability of a Couple-Based Physical Activity Intervention

PROJECT SUMMARY
Levels of physical activity (PA) among cancer survivors are low, yet PA may ameliorate difficult effects of
treatment. We focus here on PA following the most intensive form of cancer treatment, hematopoietic cell
transplantation (HCT). While potentially curative, the procedure is highly demanding, with multiple sequelae
including chemotherapy- and radiation-induced cytopenia, and cardiovascular and pulmonary complications.
PA is diminished post-transplant, and this decrease is associated with poorer physical functioning. Moderate
exercise has been deemed safe for HCT patients, and PA interventions feasible. Findings regarding efficacy,
however, are mixed, in part due to heterogeneity of intervention components and outcomes. The largest trial to
date reported null findings but the exercise intervention was self-directed (arguably light) and PA was assessed
via self-report. Findings from other studies suggest that PA may improve cardiorespiratory fitness, physical
performance, and fatigue among HCT patients. All PA interventions in the HCT setting have focused entirely
on patients, ignoring an opportunity to engage and benefit the family caregiver, a 24/7 role requiring the
provision of medical and logistical support. Distress is common among HCT caregivers and their own health
promotion is neglected. We aim to leverage the patient-caregiver relationship to improve PA among both
patients and their caregiving spouses/partners. To do so, we will test feasibility and acceptability of a couple-
based PA intervention developed for general cancer survivors and caregivers but translatable to HCT. Guided
by social cognitive theory and interdependence/ communal coping perspectives, this intervention provides
training in communication skills and joint problem-solving in the service of helping partners support one
another in PA. We have adapted this protocol for the early post-HCT setting and will use Actigraph devices to
monitor PA and inform weekly individualized step prescription. Specific aims are to: (1) Determine feasibility of
recruitment [% of eligible couples agreeing to participate], adherence [% of intervention sessions attended, #
valid Actigraph wear days, % therapeutic elements covered by therapist], and retention [% follow-up
assessments completed] in a single-site pilot RCT. (2) Determine acceptability of the intervention among
patients and caregivers (multiple dimensions of treatment satisfaction). (3) Describe patterns of change in PA
and communal coping (intervention targets) for those in the intervention relative to usual care. Findings will
inform the design of a full-scale RCT to test efficacy of the intervention to improve physical well-being, test
mechanisms of action, and identify potential moderators of treatment response. Findings will also inform efforts
to optimize the intervention for integration into standard transplant care, expanding providers' repertoire of
supportive care options. More broadly, the intervention could be adapted for different types of patient-caregiver
dyads and illness contexts.

Public health relevance
PROJECT NARRATIVE Physical functioning and physical activity are reduced following hematopoietic cell transplantation (HCT), a demanding treatment for hematologic malignancies. Family caregivers are burdened in ways that interfere with their own health promotion. This study will test feasibility and acceptability of Mates in Motion, a couple-based physical activity intervention for HCT recipients and their caregiving spouses/partners; the program prescribes weekly step (walking) goals and trains couples in problem-solving skills to support one another in the achievement of these goals.